Resiliency among Older Adults Receiving Lung Cancer Treatment: A Supportive Care Intervention Study

PROJECT ABSTRACT/SUMMARY. Lung cancer is a disease of older adults, who make up the least studied
population of patients in cancer research. Evidence gaps persist in understanding the impact of newer treatments
such as immunotherapy on functional status, the ability to recover from disability (resiliency), and clinical
outcomes (e.g. symptom burden and treatment toxicity) among older adults. Current evidence indicates that the
majority of older adults with cancer prioritize maintaining functional independence (i.e. no disability) over survival.
Despite this common desire among older adults, disability in basic activities of daily living (ADLs), instrumental
activities of daily living (IADLs), and mobility is a common consequence of cancer treatment. Functional status
in terms of ADLs, IADLs, and mobility is often unmonitored throughout the treatment course. Among older adults
with lung cancer, poor physical capability and psychological symptoms such as anxiety and depression are
common and represent potentially modifiable risk factors to achieve resiliency rather than disability. Interventions
that focus on helping older adults enhance resiliency and prevent functional decline during treatment are urgently
needed. Therefore, the objective of this application is to test a novel supportive care intervention specifically
designed to enhance resiliency among older adults with advanced lung cancer. This supportive care intervention,
called Resiliency among Older Adults Receiving Lung Cancer Treatment (ROAR-LCT), is designed to help
patients engage in behavior change to preserve functional status, by optimizing a resilience response to cancer
treatment, and is delivered virtually to decrease treatment burden for older adults. The first aim of this proposal
is to conduct the ROAR-LCT pilot randomized clinical trial, comprising physical therapy plus relaxation versus
standard-of-care, to evaluate a) feasibility and b) the preliminary effect on functional status (primary outcome).
The second and third aims are to compare secondary outcome differences (physical capability and psychological
symptoms) and exploratory outcome differences (symptom burden and treatment toxicity) between the two study
groups. As a geriatric thoracic oncologist, my overall career goal is to become an independent physician-scientist
conducting research to understand the problem of disability following a lung cancer diagnosis and developing
empirically supported strategies to improve a resilience response and prevent disability among older adults. This
award and training proposal will provide the support to advance my knowledge of patient-reported functional
outcomes for older adults, implement this knowledge in the design of behavioral clinical trials, and share this
knowledge in new leadership roles. To help ensure the success of this application, I have developed relationships
with a distinguished mentorship team having expertise in behavioral interventions, cancer control, lung cancer,
and geriatrics. This award will provide me with the additional training and career development I need to become
an independent physician-scientist focused on cancer and aging and to achieve my long-term goal of becoming
an international leader in geriatric oncology and a role model and mentor for women in academic medicine.

Public health relevance
PROJECT NARRATIVE The National Academy of Medicine has called for the inclusion of older adults in cancer research; yet, knowledge gaps remain with respect to important patient-reported outcomes, such as functional status, resiliency, and treatment toxicity, in this population. The proposed research seeks to test the feasibility and preliminary effect of one of the first virtual health supportive care clinical trials using physical therapy and progressive muscle relaxation among older adults with advanced lung cancer.